Investigating altered smooth muscle cell mechanotransduction as a cause of supravalvular aortic stenosis

ABSTRACT
Supravalvular aortic stenosis (SVAS) is characterized by focal narrowing of the aorta that increases the risk
for sudden cardiac death. SVAS is caused by mutations in the elastin gene that lead to decreased elastin
amounts and there are currently no pharmaceutical treatments. The mechanisms by which elastin insufficiency
cause SVAS are not well understood. Elastin is a critical mechanical component of the aorta and contributes to
the passive stiffness (or modulus) that determines how much the aorta will deform (or strain) under applied
hemodynamic stresses. Strain on smooth muscle cells (SMCs) within the aortic wall affects differentiation,
proliferation, and migration. Cellular transmembrane channels, including Piezo1/2, are mechanosensitive
molecules that transduce mechanical changes (such as strain) into biological effects (such as differentiation).
Activation of Piezo channels leads to increases in intracellular calcium that can stimulate nuclear translocation
of YAP/TAZ, which are transcriptional regulators of target genes including Ctgf. Ctgf is a known modulator of
SMC phenotype that encourages dedifferentiation, migration, and proliferation - all characteristics affected by
strain that may contribute to SVAS. Preliminary data in our unique SVAS mouse model (TaglnCre;Elnf/f) show
a reduced aortic modulus that may increase SMC strain, increased Piezo2 and Ctgf expression in aortic SMCs,
and a dedifferentiated aortic SMC phenotype. We hypothesize that SVAS is caused by altered SMC
mechanotransduction when enough elastin is not laid down to stiffen the aortic wall and prevent increased
SMC strain as stress increases with blood pressure during development. Increased SMC strain causes
overexpression/activation of Piezo2, leading to increased intracellular calcium, nuclear translocation of
YAP/TAZ, and increased Ctgf transcription that causes SMC phenotype modulation contributing to stenosis.
We will address our hypothesis through three complementary aims using TaglnCre;Elnf/f mice and human
SMCs derived from induced pluripotent stem cells from SVAS patients. In Aim 1, we will measure the global
and local elastic modulus of TaglnCre;Elnf/f aorta and SMC strain under physiologic loading conditions at
different developmental time points (before and after stenosis formation) and correlate these results with
changes in SMC phenotype as measured by single cell RNA-Seq. In Aim 2, we will apply strain to mouse aorta
and mouse and human SMCs and measure Piezo2 expression and activity. We will chemically and genetically
alter Piezo2 expression/activity and determine effects on in vitro calcium signaling and in vivo stenosis
severity. In Aim 3, we will chemically and genetically manipulate Piezo2 expression/activity, YAP/TAZ
localization, and Ctgf amounts in mouse aorta and mouse and human SMCs and determine the effects on
SMC phenotype and stenosis severity. Our results will be important for identifying new pharmaceutical
strategies that may prevent SMC phenotype changes in response to elastin insufficiency and treat SVAS.
.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Genetic mutations in the elastin gene cause reduced elastin protein levels and lead to severe narrowing (stenosis) of the aorta through a mechanism that is not well understood. The project will determine how mechanotransduction in smooth muscle cells within the aortic wall is modified by reduced elastin levels and how the resulting downstream signals may contribute to aortic narrowing. The results may lead to new therapeutic strategies to slow or prevent supravalvular aortic stenosis in humans.